CORE--BEHAVIORAL TRAINING CENTER

The first goal of this proposal is to provide the administrative organization for effective direction and use of resources. The second goal is to provide a centralized facility to provide young rats with early olfactory preference training. This facility should facilitate the efficient use of resources by the group and standardized procedures to make maximal use of the scientific data derived from the individual studies.